Development of a Versatile Multiplexing Nanoscopy Platform for Cell Biology

Project Summary
Understanding cellular function is intimately linked with the ability to visualize organelle ultrastructure with
molecular specificity and to observe how it is altered in diseases such as cancer, neurological disease,
ciliopathies and microbial pathogenesis. Super-resolution microscopy (SRM) has potential here as it bridges
the gap between light and electron microscopy and provides molecular specificity. However, SRM mostly offers
only a few color channels. This prohibits a comprehensive architectural map of organelles, as many are
pleomorphic and exist in multiple states depending on intra- and extracellular cues, making the combination of
datasets, each showing different subsets of labels, difficult. The SRM technique of DNA-PAINT allows, in
principle, powerful multiplexing to image 10 or more labels in one sample, but hurdles in speed, cost and ease
of use have limited its application. What is needed is a highly versatile multiplexing strategy to enable SRM of
organelles with an order-of-magnitude improvement in four key areas: acquisition speed, switching between
multiplex probe sets, spatial resolution, and cost. This requires new probes, instrumentation, enhanced
analysis, and biological validation. We will approach these tasks through three Specific Aims: 1) the
development of new versatile, DNA-PAINT probes that are both fluorogenic and provide a fast, adaptable,
low-cost framework for multiplexing, 2) a new platform for automated acquisition of multiplex DNA-PAINT data
and analytics to ‘connect the dots’ of single-molecule localization points in three dimensions and thereby create
membrane representations of organelles, and 3) the development of multiplexed DNA-PAINT ‘organelle
modules’ to validate this technology under realistic biological conditions and lower the entrance hurdle for
future biological users. Achieving these aims and their concrete deliverables will have a wide impact on the use
and accessibility of SRM to accelerate biological discovery.

Public health relevance
Project Narrative Understanding the complex nanoscale spatial architecture of organelles is highly relevant to public health as it provides mechanistic and functional insights into the cellular processes that are disrupted in cancer, neurodegenerative and developmental diseases (e.g. ciliopathies). In this project we will develop an innovative and flexible multiplexed imaging approach to visualize the nanoscale organization and remodeling of cellular organelles.